A Miniaturized Soft X-ray Microfluoroscope

DESCRIPTION (provided by applicant): This project will develop a new microscopy instrument that is, in essence, a miniaturized fluoroscope. Samples are placed in direct contact with a grainless fluorescent-screen and illuminated with soft x-rays radiated by an extremely hot laser-produced plasma. The resulting luminescent shadowgraph is observed using optical microscopy. The device can produce images showing the three dimensional structure of unstained living cells at a resolution near 100 nm. An extremely brief exposure duration of several nanoseconds results in very sharp images, even in the presence of significant specimen motility. The instrument should find widespread application in many biomedical research areas. Phase I research demonstrated the feasibility of construction such an instrument using a design that was sufficiently compact for mounting directly onto the sample stage of a commercial optical microscope. This allowed the observation of both dry and hydrated test objects using either optical microscopy or soft x-ray microfluoroscopy. Phase II research will develop an advanced version of the instrument that will take full advantage of the unique imaging characteristics of the technique. The instrument will be appropriately designed for subsequent commercialization. Testing will include evaluating the instruments effectiveness in a real research investigation. PROPOSED COMMERCIAL APPLICATIONS: The ultimate goal of this project is to produce an accessory instrument that can be used with virtually any standard optical microscope. Due to the ubiquitous nature of optical microscopy, the commercial potential of this work is very substantial. The instrument's imaging capabilities are not achievable with any existing product. In addition to basic research applications in the life sciences, this technology may find significant usage in clinical medicine.